Urologic Oncology Branch Consult Core

We are proud of the fact that we provide 24/7 medical coverage 7 days a week, 365 days a year to all services at the Clinical Center of the National Institutes of Health. We have outstanding and highly trained urologic surgeons who provides this care on the wards, in the clinic and in the operating room. If an individual clinician needs a patient seen, we are happy to see them any day of the week and on weekends. We also provide consultative care in the operating to other surgeons who need our assistance